Regulation of Neurotransmitter Metabolism

DESCRIPTION (provided by applicant): The proposed research is a continuation of our ongoing studies of mechanisms mediating glial lineage commitment and glial responses to injury. Bone morphogenetic protein (BMP) signaling promotes astrocytic and inhibits oligodendroglial lineage commitment both in vitro and in vivo. BMPs exert their biological effects by binding to type I (BMPRIa and BMPRIb) and type II (BMPRII) receptor subunits that are organized with minor modifications of the prototypical TGFbeta subclass. This proposal will examine the role of different BMPR subunits in astroglial lineage commitment and glial responses to injury, and will define molecular mechanisms underlying effects of BMP signaling on gliogenesis. Glial lineage commitment is also influenced by factors that inhibit astrogliogenesis. Beta-1 integrin signaling inhibits astrocytic lineage commitment and is able to suppress the stimulatory effects of BMP signaling. Further, activation of beta-1 integrin signaling inhibits glial hyperplasia after spinal cord injury without altering astrocytic hypertrophy. This proposal will also examine the mechanisms underlying these effects of beta-1 integrin signaling and how they modulate the effects of BMP signaling. The first specific aim will define mechanisms mediating the effects of BMP signaling on glial responses to spinal cord injury. This part of the proposal will utilize conditional null mutation of BMP receptor subunits from different populations of precursor cells and astrocytes to define the roles of different BMPR subunits in glial lineage commitment and injury responses. The second specific aim will examine the effects of conditional null mutation of beta-1 integrin or enhancement of beta-1 integrin signaling on glial lineage commitment and glial responses to spinal cord injury. A specific focus will be on mechanisms by which beta-1 integrin and BMP signaling interact and identification of the genes that are activated in response to the two signaling pathways. It is hoped that these studies will indicate biochemical loci where therapeutic intervention in disease processes may lead to a return to normal neurological function. More specifically, understanding the factors that regulate gliogenesis in the adult spinal cord may lead to therapies designed to facilitate regeneration and restoration of function.

Public health relevance
PUBLIC HEALTH RELEVANCE: After injury to the nervous system, increased numbers of cells called astrocytes accumulate at the site of the injury. These cells mediate important functions for the repair of damage to the spinal cord or brain, but they eventually lead to formation of a scar that hinders regeneration. The proposed studies will examine what controls the formation of such a scar after spinal cord injury and seek to define ways of preserving the beneficial effects of astrocytes while limiting the detrimental effects. After injury to the nervous system, increased numbers of cells called astrocytes accumulate at the site of the injury. These cells mediate important functions for the repair of damage to the spinal cord or brain, but they eventually lead to formation of a scar that hinders regeneration. The proposed studies will examine what controls the formation of such a scar after spinal cord injury and seek to define ways of preserving the beneficial effects of astrocytes while limiting the detrimental effects. __SpecificAimsTextDelimiter__ Specific Aims: The proposed research is a continuation of our ongoing studies of mechanisms mediating glial lineage commitment and glial responses to injury. Bone morphogenetic protein (BMP) signaling promotes astrocytic and inhibits oligodendroglial lineage commitment both in vitro and in vivo (1-10). BMPs exert their biological effects by binding to type I (BMPRIa and BMPRIb) and type II (BMPRII) receptor subunits (11-15) that are organized with minor modifications of the prototypical TGFb subclass of serine- threonine kinase receptors (16). The type Ia and type Ib receptors mediate different biological responses in the developing nervous system and serve different roles during astrogliosis following injury (17-21). For example, after spinal cord injury, BMPR1a signaling mediates the early beneficial phases of astrocytic hypertrophy whereas BMPR1b is involved in the later stages of glial scar progression (Progress Report). These differences may reflect, in part, differences in the regulation of microRNA21 (miR21). This proposal will examine the role of different BMPR subunits in astroglial lineage commitment and glial responses to injury, and will define mechanisms underlying the BMP effects. Glial lineage commitment is also influenced by factors that inhibit astrogliogenesis. b1-integrin signaling inhibits astrocytic lineage commitment and is able to suppress the stimulatory effects of BMP signaling. Further, activation of b1-integrin signaling inhibits glial hyperplasia after SCI without altering astrocytic hypertrophy. Since all elements of both signaling systems are present in progenitor cells in the spinal cord and brain, this suggests that interactions between these two important systems regulate the generation of astrocytes during development and after injury. This proposal will therefore examine the mechanisms underlying the effects of b-integrin signaling and how they modulate the effects of BMP signaling on generation of astrocytes. Specific Aim 1 - Define mechanisms mediating the effects of BMP signaling on glial lineage commitment and glial responses to injury. Although roles for BMP signaling in astrocyte specification and glial responses to injury are well established, the underlying mechanisms are less well known. This part of the proposal will determine the cell populations that generate astrocytes in response to BMP signaling after spinal cord injury and define the mechanisms mediating effects of different BMPR subunits in this process. a. Define the role of NG2+ cells in gliosis after SCI and differences in responses of NG2+ cells lacking BMPR1a, BMPR1b, or BMPRII. NG2-cre ERT2RosaGFP will be used to conditionally ablate BMPR subunits prior to spinal cord injury (SCI), and effects on gliosis and functional recovery will be examined. b. Define effects on astrocyte responses to injury of conditional ablation (nestin-cre ERT2RosaGFP) of BMP receptors from adult spinal cord nestin+ cells. These studies will address the potential role of spinal cord ependymal cells to astrocytic responses after SCI. c. Define the role of miR21 in GFAP expression, glial lineage commitment and astrogliosis. BMPR1a signaling increases levels of mature miR21 which regulates GFAP expression post-transcriptionally in astrocytes. This part of the proposal will examine the role of this microRNA in mediating BMP effects on GFAP expression by astrocytes and by NG2+ cells. Specific Aim 2 - Define the role of b1-integrin signaling on glial lineage commitment and glial responses to injury and mechanisms by which b1-integrin and BMP signaling interact. b1-integrin signaling inhibits astrocytic lineage commitment and is able to suppress the stimulatory effects of BMP signaling. This part of the proposal will delineate the role of b1-integrin signaling after SCI and define interactions between BMP and b1-integrin signaling. a. Define effects of b1-integrin signaling on lineage commitment by NG2+ cells and responses to BMP. The effects on lineage commitment of dominant negative or constitutively active forms of b1-integrin or IKVAV-PA will be examined in cultured NG2+ cells with and without BMP4 treatment. b. Define NG2+ cell responses to SCI after conditional ablation of b1-integrin. NG2-creERT2 will be used to conditionally ablate b1-integrin prior to SCI, and effects on gliosis and functional recovery will be examined c. Define effects of conditional ablation of b1-integrin from nestin+ cells (nestin-cre ERT2RosaGFP) on astrocytic commitment after SCI. These studies will address the potential role of b1-integrin signaling in spinal cord ependymal cells to astrocytic responses after SCI. While the proposed studies seek to define basic mechanisms regulating astrogliosis, each set of experiments is also directly related to an injury model. The goal is to identify biochemical loci where therapeutic intervention in disease processes may lead to a return to normal neurological function. More specifically, understanding the factors that regulate gliogenesis in the adult spinal cord may lead to therapies designed to facilitate regeneration and restoration of function after spinal cord injury.